The role of Pdx1-recruited Chd4:NuRD complex in controlling mature #-cell function

PROJECT SUMMARY
Pancreatic β-cells within the islets of Langerhans are required for glucose-stimulated insulin secretion
and glucose homeostasis. Dysfunctional β-cell activity and identity results in diabetes, a growing disease
affecting millions of Americans, thus creating an enormous fiscal and health burden. Strategies to improve
outcomes for the mounting number of diabetic patients requires understanding the complex programs that
coordinate a proper insulin release in response to changing blood glucose levels. Developing upon existing
knowledge of how islet enriched transcription factors (TFs) coordinate signals that influence gene regulatory
programs will allow us to understand how such programs are dramatically altered in islet β-cells of diabetes
patients. Pdx1, one of the most important TFs in the developing and postnatal β-cell, has been shown to recruit
a diverse set of coregulators which could potentially modulate its activity. This proposal is focused around how
Pdx1 interactions with the Nucleosome Remodeling and Deacetylase (NuRD) complex are influential to normal
β-cell function and are altered in pathophysiological conditions associated with the development of Type 2
diabetes (T2D).
The central ATPase subunit of the NuRD complex, Chd4, was found to interact with and control a subset
of Pdx1 target genes and is recruited to genes important for normal β-cell function in vitro. Preliminary studies
demonstrate that conditional removal of Chd4 from mature islet β-cells significantly impacts glucose tolerance in
vivo. This proposal will test the overall hypothesis that Pdx1-bound Chd4:NuRD complex controls chromatin
accessibility and gene expression programs important for physiological β-cell function which are compromised
during the development of diabetes. In Aim 1, we will fully characterize how β-cell dysfunction occurs due to the
absence of Chd4 in a new conditional Chd4-deleted mouse model and in Aim 2 we will uncover the mechanistic
actions of Chd4 in controlling chromatin accessibility and gene expression using unbiased genome-wide RNA-,
ATAC- and ChIP-Sequencing approaches. The influence of Chd4:NuRD on human Pdx1 and β-cell action will
be investigated. Aim 3 will evaluate how T2D associated stressors influence Pdx1:Chd4 interactions using
biochemical and in situ methods from rodent and human islets, in vivo models of T2D and primary human tissues.
Upon successful completion of this grant, we will have determined the mechanistic actions of Chd4:NuRD
on controlling Pdx1 activity and β-cell function, and defined how stressors associated with diabetes development
impact the vital Pdx1:Chd4 regulatory mechanisms. This research will identify critical targets that contribute to
the pathogenesis of T2D, which will open new avenues for diabetes research.

Public health relevance
PROJECT NARRATIVE Combatting the ever-growing health and economic costs associated with diabetes, it is necessary to obtain full knowledge of beta cell dysfunction occurs in the progression to diabetes. Precise gene expression programs within the beta cell are mediated by islet enriched transcription factors and recruited coregulators, whose dynamic interactions are predicted to be compromised in the pathophysiological conditions associated with diabetes. The studies herein aim to define the importance of the Nucleosome Remodeling and Deacetylase complex on modulating the activity of the Pancreas Duodenum Homeobox-1 transcription factor in physiological and pathophysiological conditions associated with Type 2 diabetes.